Induction of bnAbs against HIV-1 gp41.

PROJECT SUMMARY/ABSTRACT
Despite the availability of effective anti-retroviral drugs, there are still about 38 million people living with HIV-1
infection and about 1.5 million people became newly infected just in 2020. A vaccine is critically needed to stop the AIDS
pandemic. Induction of broadly neutralizing antibodies (bnAbs) against HIV-1 is the utmost critical goal towards the
development of a protective AIDS vaccine. In this R43 Phase I SBIR proposal, we will evaluate a novel “Antibody-
Stabilized, Epitope Presentation” (ASEP) vaccine strategy to elicit 10E8-like bnAbs against HIV-1. 10E8, a bnAb isolated
from an HIV-1-infected patient that targets the membrane proximal external region (MPER) of HIV-1 gp41, has been shown
to neutralize ~98% of all HIV-1 isolates tested. Developing immunogens and/or establishing vaccine strategies that can
induce 10E8-like bnAbs would be a major milestone towards AIDS vaccine development. Thus, our proposal is highly
significant and, if successful, this project will have great impact in the AIDS vaccine field and immunogens we generate
will be commercially valuable. The major innovation and the focus of this proposal is our ASEP vaccine strategy, in which
precisely defined immune complexes are used as immunogens. This proposal is founded on three scientific premises. (1) A
vaccine that can induce high titers of 10E8-like bnAbs will be protective against HIV-1 infections. (2) Although short
peptides are good for focusing antibody responses, they are not ideal B-cell immunogens because they are highly flexible
and can exist in many different conformations. (3) The conformation of a peptide can be fixed into a rigid structure when it
is bound to an antibody. The primary objective of this Phase I R43 feasibility study is to demonstrate MPER/Antibody
immune complexes can be used to elicit 10E8-like bnAbs against HIV-1. Successful completion of this study would
overcome a critical roadblock towards development of a protective AIDS vaccine.

Public health relevance
PROJECT NARRATIVE Antibodies that can neutralize (block) HIV-1 infection are important components of the body’s immune system. The critical roadblock to AIDS vaccine development is the difficulty in eliciting neutralizing antibodies that are broadly reactive against many different variants of the virus. It is believed that preventing a critical step of virus entry into host cells is the best strategy to develop an AIDS vaccine. However, this has been a significant scientific challenge during the past four decades. The major goal of this proposal is to generate novel vaccine candidates that can train the body’s immune system to produce antibodies that can block fusion of viral and cellular membranes. Thus, successful completion of proposed studies will overcome a critical roadblock to AIDS vaccine development.